DELAVIRDINE MESYLATE TREATMENT IN TRIPLE COMBINATION FOR HIV-1+ PATIENTS

The purpose of this study is to evaluate 1) the safety and tolerance of longterm triple therapy combinations of DLV, ZDV, and ddC, or DLV, ZDV, and ddI in HIV-1 individuals who were particants in previous protocols; 2) the efficacy of the triple therapy regimen based on changes in CD4 counts, plasma HIV-1 RNA by PCR, and on time to disease progression or death, 3) the clinical efficacy of the triple therapy regimen; and 4) to continue to follow patients from an earli study with delavirdine mesylate for pharmacoeconomic activities.